Developing Next Generation Genetics for Understanding Hematopoietic Stem Cell Biology

Project Summary:
Mouse genetic tools based on Cre recombinase and Cas9 nuclease have been applied for cell/tissue-specific
gene knockout and cell lineage tracing. These tools enable control of gene expression and genome
engineering to uncover detailed biology in a number of systems. However, the lack of precise spatiotemporal
control hinders the broader applications of these tools. In this proposal, we will develop a new set of mouse
genetic tools to address this issue. Then we propose to apply this system to investigate the establishment of
the adult bone marrow hematopoietic stem cell (HSC) pool in vivo. Because HSCs self-renew and differentiate
into all blood cell lineages throughout life, they are the basis for life-saving bone marrow transplantation in
clinics. Therefore, understanding HSC biology has important translational implications. The establishment of
the adult bone marrow HSC pool is essential for life-long hematopoiesis. However, how the adult bone marrow
HSC pool is established has not been addressed. The lack of appropriate genetic tools to study HSCs at the
clonal level in vivo has been a major hurdle. Our novel genetic tools will allow tracing HSCs at the clonal level
in vivo. If successful, the results will significantly advance the field by directly addressing how the adult bone
marrow HSC pool is established. Also, our proposed novel technologies will be widely applicable to various
research fields beyond hematopoiesis to address fundamental questions.

Public health relevance
Public Narrative: This project will investigate the mechanism underlying HSC migration using next-generation cutting-edge mouse genetic technology. Our research will provide an innovative platform to study HSC biology for further understanding how blood cells are generated and regulated in mammals.